Core C: Translational Neurosciences Core

The Translational Neuroscience Core will: 1) provide IDDRC investigators with facilities and services to support
their individual human neuroimaging and psychophysiological research programs in the area of intellectual and
developmental disabilities (IDD); 2) continue to develop trans-species methods for acquiring neuroimaging and
psychophysiological measures in humans with IDD and IDD mouse models; 3) utilize repositories of ‘big data’
at Vanderbilt to develop new tools and discoveries for IDD; 4) facilitate interdisciplinary collaborations among
IDDRC investigators who may or may not have neuroimaging expertise; and 5) ensure that the services
provided are timely, highest quality, and cost-effective. The Translational Neuroscience Core C will support
P50 users in the above areas for magnetic resonance (MR) neuroimaging as well as psychophysiological
measures. The Core’s services can be broadly construed into two different categories: (1) those that are
responsive to investigators’ needs and (2) those that are generative, and provide new directions in IDD
for investigators to leverage. Investigator need-based services provided include assistance in (a) experimental
design, including selecting appropriate tasks for magnetic resonance imaging (MRI) or electroencephalogram
(EEG)/event-related potentials (ERP), (b) identification of the optimal modalities of MR imaging or
EEG/ERP/eye tracking acquisition parameters (c) implementation of MRI and EEG/ERP data collection with
special populations (individuals with various IDDs, especially infants and children), and (d) management and
analysis of MRI and EEG/ERP/eye tracking data. The generative and innovative component of the
Translational Neuroscience Core C focuses on key areas that are of particular interest for IDD researchers:
design of novel experimental paradigms optimized for IDDs, expanding trans-species imaging capabilities,
implementing and augmenting novel data acquisition and analysis methods for measuring neural biomarkers of
IDD, developing robust image processing techniques to handle challenging data (e.g., movement artifacts),
and providing tools to enable optimal establishment, usage, and analysis of ‘big data’ repositories such as
ImageVU. While expertise and resources in neuroimaging, advanced computing, and data management tools
are available at Vanderbilt University, none are tailored for the special needs of those who study IDDs.
The Aims and services in Core C all have the central goal: facilitate cost-efficient discovery that leads to the
prevention and/or amelioration of IDD. Each member of the Core has strong ties to the larger Vanderbilt
community, thus enabling seamless linkages between entities at Vanderbilt that are critical for the Core. The
Core will serve 22 funded IDD research-related projects.

Public health relevance
PUBLIC HEALTH RELEVANCE: As a group, intellectual and developmental disabilities, including Down syndrome and autism spectrum disorder, have dramatic effects on affected people’s and their caregiver’s lives. Unfortunately, there remains a lack of understanding about what causes these disabilities and, critically, how to treat them with targeted therapies. The Vanderbilt Kennedy Center’s Intellectual and Developmental Disabilities Research Center serves as the hub for Vanderbilt’s research efforts focusing on improving the lives of people with intellectual and developmental disabilities by understanding the causes of these disorders and developing and testing therapies tailored to each individual’s precise needs.